Regulation of Neurodegeneration by Nonpathogenic Cellular Prion Protein and LRP1

Microglial activation and neuro-inflammation regulate disease progression in diverse neurodegenerative di-
seases (NDs), including but not limited to Alzheimer's Disease, Parkinson's Disease, and Tauopathies. Under-
standing pathways that regulate neuro-inflammation in NDs is a significant goal. Cellular Prion Protein (PrPC) is
best known as a GPI-anchored membrane protein that, in rare circumstances, undergoes conformational change
to generate a derivative that aggregates in the brain, causing rapid ND and death. Pathogenic PrPC is trans-
missible. Non-pathogenic PrPC is expressed widely, inside and outside the CNS. Numerous studies in diverse
mouse model systems have shown that PrPC attenuates inflammatory responses, including neuro-inflammation.
We contributed to this field by identifying a system of receptors that mediates the anti-inflammatory activity of
PrPC in macrophages when PrPC is released from cells by ADAM family proteases (S-PrP) or in exosomes and
other extracellular vesicles (EVs). This receptor system includes LDL Receptor-related Protein-1 (LRP1) and
the NMDA Receptor (NMDA-R). Binding of PrPC derivatives to the LRP1/NMDA-R receptor assembly in mac-
rophages blocks pro-inflammatory responses initiated by diverse Pattern Recognition Receptors. We now have
data showing that the PrPC-LRP1/NMDA-R interaction initiates anti-inflammatory cell-signaling in microglia. We
also have shown that the anti-inflammatory activity of S-PrP may be harnessed in small synthetic peptides (14-
mers, 4-mer) corresponding to a putative LRP1-binding motif in PrPC that includes Lys100 and Lys103. The major
goal of this research project is to characterize the activity of PrPC and the LRP1/NMDA-R receptor system in
neuro-inflammation in NDs. A second goal is to test whether PrPC derivatives may be administered therapeu-
tically to amplify the activity of the microglial LRP1/NMDA-R system and thereby attenuate neuro-inflammation.
Three specific aims are proposed. In Specific Aim 1, we will test the ability of anti-inflammatory PrPC derivatives
to regulate microglial activation and secretion of pro-inflammatory mediators by microglia and astrocytes in res-
ponse to proteins that accumulate and aggregate in the extracellular spaces of the CNS in various NDs, including
amyloid-β (Aβ), microtubule-associated protein Tau, and α-synuclein. In Specific Aim 2, the effects of PrPC gene
(Prnp) deletion on biomarkers of microglial activation and neuro-inflammation will be studied in three distinct
mouse models of ND, including AppNL-F mice, P301S-Tau transgenic mice, and mice that receive intracerebral
injections of α-synuclein pre-formed fibrils. In Specific Aim 3, we will replicate the studies proposed in Specific
Aim 2, studying tga20 mice, which express 3-4× more PrPC in the CNS compared with wild-type mice. Next, we
will exploit the known ability of LRP1 to serve as a Blood-Brain Barrier Trojan Horse-receptor that transports
proteins into the CNS and test whether systemically administered PrPC-derived proteins and peptides augment
the anti-inflammatory activity of the microglial LRP1/NMDA-R receptor system in the CNS. Collectively, these
studies will elucidate a novel anti-inflammatory system that may be highly significant in diverse NDs.

Public health relevance
In this research project, we will elucidate the pathway by which nonpathogenic cellular prion protein (PrPC) ex- presses anti-inflammatory activity in the CNS, determine the role of LRP1 as a mediator of this activity, test whether PrPC regulates neuro-inflammation in mouse models of neurodegenerative diseases, and determine whether the activity of the PrPC-LRP1 system may be augmented therapeutically to control neuro-inflammation in neurodegenerative diseases.